Early Stress and the Neurobiology of Susceptibility and Resilience to Substance Use Disorders

Summary'
Childhood maltreatment is the most important risk factor for substance use, with maltreatment and household
dysfunction accounting for about two thirds of the population attributable risk for drug dependence and iv drug
use. Hence, there is a substantial subset of individuals with substance use disorders who experienced
maltreatment and a substantial subset who did not. Those with maltreatment tend to have an earlier age of onset,
more severe course, more comorbid symptoms, higher rates of relapse following treatments, and are more likely
to have abnormalities in brain morphology. A critical question is whether the maltreated ecophenotypic variant
is a distinctly different disorder or simply a more severe manifestation of the same underlying disorder. Our
previous efforts during the first ten years of this award resulted in important new discoveries regarding type and
timing of maltreatment, gender differences, predisposing symptoms and specific brain changes that were
prospectively predictive of risk for developing substance use problems in maltreated youths. Our goal during this
phase of the award is to compare maltreated and non-maltreated individuals with histories of “hard drug”
substance use disorders, with opioids as primary drug of abuse, as well as unexposed non-substance using
controls, to provide the first comprehensive test of the ecophenotype hypothesis that there are unique maltreated
and non-maltreated substance use disorder subtypes with distinctly different molecular and neurobiological
signatures. We further propose that neurobiological alterations associated with attention deficit hyperactivity
disorder serve as the primary risk factor in the non-maltreated subtype rather than brain changes associated
with early life stress and maltreatment. Verifying that there are two distinctly different pathways to substance
use disorders would have critically important implications for prevention, treatment and design of future
research studies, as each pathway may require distinctly different strategies for prevention, treatment and
discovery. The second aim of the award will be to determine how exposure to maltreatment during sensitive
periods becomes biologically embedded and to specifically determine how much inflammation and sleep stage
disruption mediate the effects of maltreatment on brain morphometry, brain network architecture and
symptoms predisposing to substance use. The purpose of this aim is to identify the most important mediators as
potential therapeutic targets to prevent the emergence of substance use disorders in high-risk maltreated youth.
Further, ongoing effects of inflammation and sleep disruption on neurobiology and behavior may serve as a
barrier to recovery and targeting these mediators in maltreated individuals with opioid and other substance use
disorders may facilitate recovery. Hence, one aim of this award is to markedly advance our understanding of
substance use by testing the hypothesis that maltreatment and ADHD are not just risk factors for substance use
disorder but distinctly different pathways, while the second aim is to discover potential therapeutic targets to
prevent emergence of substance use and to facilitate recovery.

Public health relevance
Narrative During the previous period of support we identified brain regions and clinical symptoms affected by childhood maltreatment that prospectively increased risk for substance use and created the Maltreatment and Abuse Chronology of Exposure scale and novel AI procedures to identify type and timing of maltreatment that were the most important predictors of brain changes and risk for substance use. One aim of this continuing program of research is to provide the first rigorous test of our hypothesis that maltreated and non-maltreated individuals with substance used disorders have distinctly different neurobiological signatures, and that maltreatment and attention-deficit hyperactivity disorder represent two distinctly different pathways to substance use, with far reaching implications for prevention, treatment and discovery. The second aim is to determine the degree to which inflammation and sleep stage disruption mediate the association between sensitive period exposure, brain changes and clinical symptoms in order to identify mediators that can be targeted to prevent the emergence of substance use in high-risk maltreated individuals and to potentially augment the effects of treatment in substance users.